Advancing the Study of Personality, Interpersonal Stress, and Cognitive Aging Through The Use of Integrative Data Analysis

Project Summary
Personality traits and interpersonal stress are important predictors of cognitive aging and dementia risk. There
is a growing interest whether the influence of developmental pathways of personality and stress on Alzheimer’s
Disease & Related Dementias (ADRD) varies at different stage of life. This application proposes a well-focused
secondary analysis to investigate a novel approach to the study of personality, interpersonal stress, cognitive
decline, and ADRD. We will leverage the unique expertise of the investigative team to conceptually harmonize
key variables across multiple NIA-supported studies to identify socioeconomic mediators of cognitive health
disparities across socioeconomic status and age. Aim 1 focuses on longitudinal associations among
personality, stress, and cognitive health across up to 14 longstanding observational studies of aging. Using the
theories of selective optimization with compensation (SOC) and the life course model of personality (LCP), we
examine how changes in personality and stress are related to cognitive aging and ADRD. We will ascertain
whether the strength of these associations varies at different stages in life and across socioeconomic statuses
(SES). In Aim 2 we examine mediators and moderators, specifically whether associations among personality,
interpersonal stress, cognitive decline and ADRD operate through behavioral pathways (e.g., smoking,
drinking) or physiological pathways (e.g., biomarkers). We explore whether mediation models are moderated
by age and socioeconomic risk factors, using the resource substitution hypothesis as our guide. In Aim 3 we
address reciprocal relationships among personality, interpersonal stress, and cognitive decline. We will test
intraindividual associations among changes in personality, changes in interpersonal stress, and changes in
cognitive function, and assess whether these effects are moderated by age or SES. Testing intraindividual
associations will provide evidence about causality and more precisely inform early intervention efforts. Using
up to 14 large existing longitudinal studies, this is among the first of its kind to leverage multiple studies to
examine dispositional and social experience on cognitive aging and ADRD over difference stages of life and
across socioeconomic contexts. The research will enhance the replicability and generalizability of our findings.
These aims are highly significant and have potential for high impact as they will provide a better understanding
of successful aging. The results from this work will provide potentially useful targets for prevention, and the
knowledge gained will help researchers, health practitioners and policy makers make decisions about
preventive medicine approaches to optimizing cognitive health across the lifespan.

Public health relevance
Project Narrative Personality traits and interpersonal stress have been linked to cognitive decline and Alzheimer’s Disease and Related Dementias (ADRD) in older adulthood, but little is known about the longitudinal interplay between these factors. It is essential to understand more precisely the pathways through which personality traits, interpersonal stress, and cognitive decline and ADRD are related; the current application therefore focuses on the role of potential behavioral and physiological factors that mediate (i.e., health behaviors, inflammatory biomarkers) these associations, as well as age and socioeconomic status as potential moderators. The use of secondary analysis on multiple large existing longitudinal datasets of aging and dementia will enhance replicability of results and will provide a cost-effective body of evidence that can inform future studies of relevance to clinical aging research.